Identifying placental tissue tropism and cellular mechanisms of Ebola Virus transmission from mother to fetus in pregnancy

Project Abstract
Maternal viral infections during pregnancy may result in catastrophic outcomes for her health as well as for her
developing fetus. Recent emerging virus epidemics and pandemics such as those with Ebola Virus (EBOV),
Zika Virus (ZIKV) and SARS-CoV-2 have highlighted the impact of viral infection on pregnancy outcomes. Yet
a dearth of data exists pertaining to viral infection and pathogenesis in the placenta and the role of the placenta
in viral transmission to the fetus. In pregnancy, EBOV infection of pregnant mother results in ~100% fatality for
her fetus or neonate with ~60% maternal mortality. Placental immunostaining from EVD outbreaks in Africa
demonstrate viral antigen in placental tissues as well as viral RNA in neonates or fetuses of infected mothers.
This suggests vertical transmission of virus from mother to fetus. However, rigorous experimental evaluation of
maternal transmission and placental infection has not been performed. The tropism of EBOV for placental
cells, mechanisms of cellular entry and route of infection from mother to fetus are currently unknown. The long-
term goal of this proposal is to understand the biology of EBOV in pregnancy through understanding a) the
tropism of EBOV within placental tissues that may lead to the transplacental transmission of virus from mom to
baby as well as b) cell surface receptors utilized by EBOV within placental tissues. Aim1 will seek to define the
tropism of EBOV in the placenta in early and late pregnancy. For these tropism studies, we will use a model
virus, recombinant vesicular stomatitis virus expressing EBOV glycoprotein (rVSV/EBOV GP), to examine viral
tropism in placental and fetal tissues. Using this model, we will explore the role of maternal and placental
macrophages as well as placental trophoblasts driving tropism. In Aim 2, we will investigate the role of
phosphatidylserine (PS) receptors in the placental infection and transmission of virus from placenta to the
fetus. In Aim 3, collaborative efforts by Dr. Andrea Marzi at Rocky Mountain Laboratories will utilize mouse-
adapted EBOV (maEBOV) in WT C57BL/6 mouse timed-pregnancies to evaluate virus load and tropism at
later gestational times. Further, maEBOV-infected placental and fetal tissues will be evaluated for targeted
innate immune responses. The data garnered from these targeted and rigorous experiments will establish the
first pregnancy model of EBOV, allowing us to mechanistically explore EBOV tropism required for the virus to
traffic from dams to fetuses. These studies will provide fundamental information on EBOV biology that will aid
in the discovery or development of therapeutic interventions for EBOV infection during pregnancy.

Public health relevance
Project Narrative In the setting of pregnancy, infection with Ebola Virus (EBOV) resulting in the Ebola Virus Disease (EVD) leads to nearly 100% loss of the fetus or neonate, with or without the additional death of the mother. This proposal seeks to evaluate the tropism of EBOV within placental tissues, transmission of EBOV across the placenta to the fetus, as well as to define the role of cell surface receptors that may influence the tissues infected or timing of placental infection and transmission. The data from this project will ultimately help us understand the barrier role of the placenta during viral infections, but also will shed light on that pathogenesis of EVD in pregnancy in order to develop therapeutics or interventions to improve outcomes for mothers and their children.